ADMINISTRATIVE CORE A3 - PROGRAM DEVELOPMENT & PILOT PROJECTS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Recruitment is an integral part of the long-range plan to build a critical mass of multidisciplinary investigators who share common interests in cardiovascular sciences. To implement Aim #3, we will dedicate a component of our Administrative Core to faculty recruitment. The main point to be made here is that these will be new faculty recruitments for investigators at any carreer stage who can bring new, critical technologies, skills, or systems into the COBRE. These recruitments are not designed to identify or recruit additional target investigators who may have an opportunity to join the program one or more initial target investigators "graduate". These are envisioned as separate activities that are both needed to build critical mass.